Neutrophil-driven vascular inflammation in VCID and Mixed Alzheimer's Disease

Summary: Substantial reductions in brain blood flow are found in patients with and mouse models of
neurodegenerative diseases, including Alzheimer’s Disease (AD). Vascular pathologies are prevalent in an aging
population and patients with AD. Despite their importance, vascular contributions to cognitive impairment and
dementia (VCID) and the interaction with AD are understudied. We have previously shown that neutrophils block
blood vessels and contribute to blood flow reductions and cognitive decline in mouse models of AD. However,
there is a knowledge gap on how and when neutrophils change and become activated, thus driving
interactions with the microvasculature to cause neuroinflammation and cognitive impairment.
We hypothesize that neutrophils become activated by hypoperfusion and AD pathology causing neutrophil-
vascular dysfunction and neurodegeneration; this is likely exacerbated in mixed forms of AD. Aim1 will use
longitudinal in vivo two-photon imaging to determine how and when neutrophils become reactive. We will also
characterize cerebral blood flow, capillary stalling, neutrophil behavior, blood-brain barrier permeability, and
vascular inflammation in a VCID, AD, and mixed AD mouse model. In Aim 2, we will utilize single-cell sequencing
of neutrophils to determine whether certain neutrophils become more reactive in our disease models, and
whether disease-associated neutrophil subpopulations drive disease progression. Furthermore, we will elucidate
the molecular mechanisms that drive neutrophil changes, focusing on metabolism and glycosylation. Last, we
will functionally test if neutrophils can be stopped from being activated and slow down disease progression.
In summary, we will determine how hypoperfusion and AD pathology lead to changes in neutrophil reactivity and
how such changes contribute to microvascular damage. We expect this work to lead to the identification of
disease stage-specific biomarkers and shed light on the contribution of activated neutrophils to VCID and mixed
AD.

Public health relevance
Narrative Blood flow to the brain is reduced in vascular dementia and mixed forms of Alzheimer’s disease, but it is unknown how or why this happens. Our recent work suggests that white blood cells interact with the smallest blood vessels, the capillaries, contributing to reduced blood flow and cognitive impairment. The proposed project examines mouse models of vascular dementia and Alzheimer’s disease over time to investigate why and how white blood cells contribute to vascular damage, will closely examine molecular changes in white blood cells driving blood flow reductions and inflammation, and is expected to lead to an understanding of how the brain communicates with the periphery, driving neurodegenerative diseases.